A 5-HTergic DRN vCA1 circuit and Alzheimer's disease

PROJECT SUMMARY
Despite the tremendous efforts in Alzheimer’s disease (AD) research, we have not made much progress in
understanding the pathophysiology of AD or inhibiting/correcting AD-related behavioral symptoms. The recent
FDA-approved aducanumab demonstrated significant efficacy in reducing amyloid β (Aβ). Still, it showed a
limited effect in improving AD-related memory impairments. The specific neural circuits that mediate these
cognitive processes but are altered progressively in the AD brains may serve as a treatment target after the
removal of Aβ plaques. In my previous studies, I demonstrated that dorsal Raphe nucleus (DRN) serotonin (5-
HT) neurons provide monosynaptic inputs to the hippocampal ventral CA1 (vCA1). Further, genetic ablation of
5-HT synthesis selectively in these vCA1-projecting DRN neurons impaired spatial memory in young mice. In
addition, genetic deletion of the 5-HT 2C receptor (5-HT2CR) in the vCA1 led to spatial memory deficits in young
mice. I also observed that lorcaserin, a selective agonist of 5-HT2CR, can ameliorate spatial memory deficits in
a 6-month-old knock-in AD mouse model (APPNL-G-F), associated with restoration of synaptic plasticity in vCA1
neurons. Together, I developed a hypothesis that a 5-HTergic DRN to vCA1 circuit regulates spatial memory via
5-HT2CR, a therapeutic target for memory symptoms in Alzheimer’s disease. The K99 phase will focus on the
upstream node of this circuit, the vCA1-projecting 5-HT neurons. Fiber photometry experiments will be used to
monitor the real-time activity of these vCA1-projecting 5-HT neurons, as well as 5-HT release in the vCA1,
corresponding to memory acquisition and retrieval behaviors. The intersectional retrograde chemogenetic
approach will be used to further test whether inhibition of the vCA1-projecting 5-HT neurons would inhibit memory
function and whether activating these neurons would rescue memory impairments in APPNL-G-F mice and aged
mice. During the R00 phase, I will utilize the techniques and the problem-solving experience I acquire from the
K99 phase to test the functional significance of the downstream 5-HT2CR-expressing vCA1 neurons. I will use
fiber photometry to monitor the activity of 5-HT2CR-expressing vCA1 neurons during the memory test and will
use the chemogenetic approach to assess the functional relevance of these neurons in memory function. In
addition, I will also test the combination treatment of Aβ-lowering (aducanumab) and 5-HT2CR agonism
(lorcaserin) in APPNL-G-F mice and aged mice. The proposed studies will advance our knowledge of the circuitry
mechanisms underlying memory function and evaluate the possibility of 5-HT2CR agonism as a novel therapeutic
target for AD in combination with Aβ-reducing medications. In addition, the K99 phase will provide an ideal
training opportunity to equip me with essential techniques, knowledge, and problem-solving skills. These will
prepare me for the R00 phase of research and an independent research career focusing on circuitry mechanisms
of different behaviors.

Public health relevance
PROJECT NARRATIVE The recent FDA-approved Aducanumab treatment for Alzheimer’s disease (AD) demonstrated its efficacy in reducing amyloid β levels without cognitive benefits in AD patients, leaving us facing the AD crisis with no cure. This proposal will focus on a 5-HTergic circuit that undergoes permanent damages from the amyloid β depositions and accounts for memory deficits in AD pathophysiology, and evaluate the possibility of targeting this circuit to treat AD/aging-associated memory impairments in combination with the amyloid β-lowing strategy.